Molecular analysis of mother-to-child transmission of hepatitis B virus

Hepatitis B virus (HBV) can cause severe liver diseases including cirrhosis and hepatocellular carcinoma
(HCC). There are approximately 254 million people in the world that are chronically infected by this virus,
resulting in more than 1 million deaths every year. Most chronic HBV carriers acquired the virus early in life from
their infected mothers. In contrast to the mother-to-child transmission (a.k.a. vertical transmission), patients who
acquired HBV from unrelated individuals (a.k.a. horizontal transmission) usually developed self-limited acute
infection. The goal of our research is to understand how HBV and its antigens in the mother affect anti-HBV
immunity of her children to promote chronic HBV infection in the latter. HBV has a very narrow host range, which
has greatly hampered its research. We have developed a mouse model to study how HBV in the mother affects
anti-HBV immunity of her children. By crossing female hemizygous HBV transgenic mice to male naïve mice, we
obtained non-transgenic mouse pups. When the HBV genomic DNA was introduced into the liver of these non-
transgenic mouse pups by hydrodynamic injection, HBV persistently replicated in these mice for up to 28 weeks.
In contrast, HBV was not able to persist in control mice born to non-transgenic dams and was cleared from the
mice within 4 weeks after the DNA injection. Our further studies indicated that maternal HBV could educate fetal
Kupffer cells (i.e., hepatic macrophages) of the offspring in utero. These Kupffer cells would then undergo M2-
like anti-inflammatory polarization to suppress HBV-specific CD8+ T cells after birth, resulting in HBV persistence
in the offspring. In contrast, Kupffer cells of the offspring that were not exposed to maternal HBV in utero would
undergo the M1-like proinflammatory polarization to promote HBV clearance. During this grant period, we will
continue to investigate how maternal HBV and its antigens affect offspring immunity against HBV. Specifically,
we will identify maternal HBV factors that promote and support HBV replication in the offspring and their effects
on anti-HBV immunity of the offspring. We will also examine the molecular mechanism by which HBV and its
antigens use to cross the placental barrier to education fetal immunity. As our preliminary studies suggested that
maternal HBV antigens could genetically reprogram fetal Kupffer cells to result in their distinct anti-inflammatory
response to HBV after birth, we will also determine the molecular mechanism of this reprogramming. Our
proposed studies will provide important information for us to understand how HBV and its antigens in the mother
affects anti-HBV immunity of her children to promote HBV replication and persistence after its mother-to-child
transmission. This information will be important for the development of novel treatments for chronic HBV patients.

Public health relevance
PROJECT NARRATIVE Chronic hepatitis B virus (HBV) infection can lead to severe liver diseases and is responsible for more than 1 million deaths every year in the world. Most chronic HBV carriers acquired the virus from their mothers. The goal of our proposed research is to understand how HBV in the mother affects the anti- HBV immune response of her child to promote chronic HBV infection in the latter, with the eventual goal of developing better treatments for HBV patients.